DETERMINATION OF DOMAIN STRUCTURE OF (70 SUBUNIT OF E COLI RNA POLYMERASE

E. coli RNA polymerase contains a catalytic core of two ( subunits, one (, and one (' subunit, with molecular masses of 36,512 Da, 150,619 Da, and 155,162 Da respectively. The core enzyme is a nonspecfic DNA binding protein that initiates transcription efficiently with little specificity. The holoenzyme has an additional regulatory subunit, most commonly (70, of molecular mass 70,236. By virtue of the ( subunit, the holoenzyme recognizes only specific, duplex DNA sequences (promoters) and initiates transcription efficiently from these sites. The (70 subunit has been cloned and overexpressed in E. coli since the early 70's. Much effort has gone into its crystallization without success. We would like to undertake structural studies of (70 and of its fragments free and bound to DNA. We have begun by investigating the properties of (70 under conditions of limited proteolysis. Mass spectrometric analysis of the proteolytic fragments were used to define domains with in (70 a nd also to determine proximate of components of the protein to RNA. A paper describing this work has been published. (E. Severinova, K. Severinov, D. Fenyo, M. Marr, E.N. Brody, J.W. Roberts, B.T. Chait, S.A. Darst "Organization of the Escherichia coli RNNA polymerase (70 subunit" J. Mol. Biol. 263 (1996) 637-647). Efforts are continuing to elucidate the interaction Cont.. of (90 with the other components of the holoenzyme. Y. Wang, K. Severinov, N. Loizos, D. Fenyo, EW. Heyduk, T. Heyduk, B.T. Chait, S.A. Darst "Determinants for Escherichia coli RNA Polymerase Assembly within the b subunit" J. Mol. Biol. (1997) 648-662.